Leveraging arginine catabolism to treat metabolic diseases

ABSTRACT
Intermittent fasting and caloric restriction are effective therapies against insulin resistance (IR) and non-alcoholic
fatty liver disease (NAFLD). Yet, intensive lifestyle modifications are rarely sustainable. We made the provocative
discovery that modulating systemic arginine status is sufficient to mimic the therapeutic effects of generalized
caloric restriction on hepatic steatosis. This is clinically significant, because targeting arginine is a tractable
pathway through which to treat metabolic disease. Accordingly, our long-term goal is to define the signaling
cascades underlying adaptive hepatic glucose fasting, so that we can identify new therapies that leverage these
pathways against IR, and NAFLD. Our unbiased transcriptomic screening in fasting mice identified a novel
glucose fasting-induced effector: the amino acid hydrolase, arginase 2 (ARG2). Our new data demonstrate that
forced hepatocyte-specific Arg2 expression reduces peripheral insulin resistance and hepatic steatosis in
diabetic mice. Because hepatocyte arginine fate depends upon competition between ARG2 and the lysosomal
arginine sensing machinery that dictate autophagic flux, and the pro-inflammatory enzyme, inducible nitric oxide
synthase (iNOS), we hypothesize that fasting-induced hepatocyte ARG2 attenuates insulin resistance and
hepatic steatosis by depleting hepatocyte arginine. To test this, we will: 1) examine pleiotropic therapeutic
mechanisms of ARG2 action against insulin resistance and hepatic fat accumulation; 2) examine small-molecule
and advanced biological therapeutics that mimic the therapeutic actions of ARG2 activation and 3) define their
mechanistic underpinnings though single-cell sequencing. Completing these aims will: 1) establish arginine
status as a determinant of metabolic homeostasis; 2) identify how modulating arginase activity impacts
physiological outcomes; and 3) examine the efficacy and mechanisms of novel therapies against insulin
resistance and NAFLD.

Public health relevance
PROJECT NARRATIVE Fasting and caloric restriction are effective to treat patients with pre-diabetes or non-alcoholic fatty liver disease (NAFLD), but intensive lifestyle changes are difficult for many to implement and sustain. We discovered a key pathway in the liver, which is activated during fasting, and is sufficient to treat pre-diabetes and NAFLD in mice. In this proposal, we will define how ARG2 mediates its therapeutic effects, and examine its efficacy to bring forth new therapies that mimic the actions of ARG2 to ultimately treat obesity-related metabolic disease.